Correlates of innate and T-cell immunity in seropositive and serodiscordant subjects for Trypanosoma cruzi infection.

Project Summary
Correlates of innate and T-cell immunity in seropositive and serodiscordant subjects for
Trypanosoma cruzi infection.
T-cell function is central to the control of T. cruzi. When immune control is inefficient, parasite load
and inflammation, and thus the potential for tissue damage, increase. The observation that subjects with
one positive conventional test out of three performed as recommended by WHO for the diagnosis of Chagas
disease, regarded as “serodiscordant subjects”, have more functional T. cruzi-specific T-cell responses, and
the responses are of a higher magnitude compared with those of seropositive chronically T. cruzi-infected
individuals suggests that some subjects exposed to T. cruzi might actually resolve the infection. The
hypothesis to be tested in the proposed study is that serodiscordant subjects who are presumed to have
cleared the infection would display not only high functional T-cell responses but also heightened innate
immune responses. The study will also explore the extent to which innate immune responses are exhausted
during the chronic phase of the infection. Based on extensive preliminary data produced in the applicants’
laboratories, these hypotheses will be tested by pursuing three specific aims: 1) determine the levels,
phenotype and function of innate immune cells in serodiscordant and seropositive subjects for T. cruzi
infection and their association with T-cell responses; 2) determine the levels of T. cruzi-specific memory and
antibody-secreting cells and the activation status of total B cells in serodiscordant subjects; and 3)
determine the effect of treatment with benznidazole on innate immune responses and the association with
changes in T-cell responses. Under Aim 1, the frequencies, phenotype and function of natural killer (NK)
cells, innate lymphoid cells (ILCs) and monocyte subsets will be measured in serodiscordant subjects in
comparison to chronically T. cruzi-infected subjects with different degrees of cardiac dysfunction. Innate
immune profiles in these subjects will be correlated with T. cruzi-specific T-cell responses, extensively
characterized by our group. Under Aim 2, we will answer the question of whether the low levels of T. cruzi-
specific antibodies in serodiscordant subjects are associated with a skewed presence of memory B cells vs.
antigen-driven antibody-secreting cells specific to T. cruzi antigens. The activation status of total B cells will
also be determined in serodiscordant subjects and compared with the findings in seropositive subjects.
Finally, under Aim 3, we will explore the extent to which treatment with benznidazole in chronically T. cruzi-
infected subjects induces changes in innate immune responses and whether successful treatment might be
predicted by a combination of changes in innate and adaptive immune parameters. The proposed study is
innovative because we postulate that the induction of efficient T-cell and innate immune responses might
eventually cure or control T. cruzi infection. Completion of the experiments proposed in this project will
provide insights into the meaning of serodiscordance for T. cruzi infection. These contributions will be
significant for understanding the relationship between adaptive and innate immune responses in relation to
cardiac dysfunction and how these responses are modulated by etiological treatment.

Public health relevance
Project Narrative Correlates of innate and T-cell immunity in seropositive and serodiscordant subjects Trypanosoma cruzi infection. Chagas disease, caused by the intracellular pathogen Trypanosoma cruzi, is the highest impact parasitic disease in Latin America and the most common cause of infectious myocarditis in the world. The aim of this project is to establish the phenotype and functional profile of adaptive and innate immune responses that is best associated with disease control. The ultimate goal of this project is a broader understanding of the immunological basis of cure, either spontaneous or drug-induced.